NOREPINEPHRINE CLEARANCE--CLINFO DATA FILE

To create and maintain a Clinfo study data file for the purpose of quality control of norepinephrine clearance studies to be done under different protocols on the Clinical Research Center.